COENZYME Q10 IN AGING: A PILOT STUDY

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. We propose to conduct a study to find out if the procedures and length of visit for a future research project are acceptable to research subjects and meet the overall needs of the future project. Our primary outcomes are to determine the length of the proposed visits, subject feasibility and acceptability for the length of the visits, subject feasibility and acceptability to complete and understand the quality of life and neuropsychological measures, and subject comprehension of a proposed consent form.